NRSA Training Core

Kidney, urologic, and nonmalignant hematological (KUH) diseases contribute to morbidity, mortality, and
escalating healthcare costs. A multidisciplinary workforce of KUH scientists is needed to pioneer new
discoveries and translate them into effective strategies for diagnosis and treatment This TL 1 Training Core will
integrate - for the first time - physician and PhD trainees across adult and pediatric KUH scientific areas at the
University of Washington and its partnering institutions and foster their success in a scientific research career.
This Training Program will recruit, select, and support 12 trainees per year in KUH science to be distributed as
8 postdoctoral trainees (postdoctoral physician and PhD scientists) and 4 predoctoral PhD students who are
pursuing KUH research in an accredited degree program at the UW. Trainees will have wide ranging
opportunities to conduct their research with at least one of 61 faculty mentors who lead actively funded KUH
research and demonstrate a track record of successful mentorship. The Program will support trainees through
structured plans for mentorship, systematic approaches for setting and monitoring goals, and consistent
mechanisms for evaluation.
This Training Program will be supported by the Professional Development Core, which will bolster trainees'
scientific and career development skills by delivering customized educational programs and research
resources. The Training Program will be further supported by the Network Core, which will build community
among trainees by creating a Virtual Platform that connects all Program activities, implementing a peer and
near peer mentorship program, and other networking activities. A Diversity Team, led by the Vice Dean of
Equity, Diversity, and Inclusion will strive to increase representation of trainees, faculty, and leaders from
underrepresented backgrounds by forging partnerships with key stakeholders. Five-year goals of the Program
are for >50% of physician trainees to obtain career development awards and > 75% of PhD students to
complete their degree and enter careers in KUH science.

Public health relevance
PROJECT NARRATIVE Please see the Overall Core for the project narrative encompassing all cores.